Genome and epigenome editing of induced pluripotent stem cells for investigating osteoarthritis risk alleles

Abstract
Genome wide association studies (GWAS) in large cohorts have identified and replicated robust single
nucleotide polymorphisms (SNPs) with a strong association to osteoarthritis (OA) development. While many
SNPs have been identified as risks for OA development, a mechanistic understanding of their role in cartilage
homeostasis and mechanobiology has remained elusive. We propose to use a novel in vitro system
combining genome editing of human induced pluripotent stem cells (iPSCs) and cartilage tissue engineering
for studying the functional effect of identified OA SNPs on the biochemical and mechanical properties of
articular cartilage. In preliminary data, we reported a functional characterization of rs11780978 in which we
identified an expression quantitative trait locus (eQTL) operating on the gene PLEC in the cartilage of patients
with OA. Our primary hypothesis is that OA-associated SNP rs11780978 results in reduced expression of
PLEC in chondrocytes secondary to altered epigenetic regulation at this locus. Using CRISPR-Cas9 and
dCas9TET-mediated genome editing, we will examine the role of genetic and epigenetic modulation (PLEC
knockout and hypomethylation of the functional region) on the chondrogenic differentiation of hiPSCs.
Furthermore, we propose that reduced production of plectin due to this SNP alters the response of
chondrocytes to mechanical stress under physiologic or pathologic conditions. This tissue-engineering
approach provides a model system that can be used in future studies to examine specific mechanistic
hypothesis on the link between OA-associated SNPs and the regulation of chondrocyte physiology.
Identification of these mechanisms will hopefully lead to new therapeutic targets for preventing or slowing OA
progression.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA) is a major cause of disability worldwide, and the risk for developing OA is associated by the presence of particular genetic variants. This project will examine how a specific genetic variation alters cartilage development and its response to mechanical loading by combining the fields of tissue engineering and genome editing to create cartilage from stem cells that have been modified to contain the gene variant of interest. Identification of these mechanisms will hopefully lead to new therapeutic targets for preventing or slowing OA progression.